Understanding the role of paraventricular neurotensin neurons in valence processing

ABSTRACT
A hallmark of substance use disorders is continued drug use despite profound adverse consequences. While
studies in rodents have suggested that leveraging both positive and negative valence processing can affect
this compulsive pattern of reward-seeking behavior in conflict with punishment, the underlying mechanisms
that regulate valence processing and guide ultimate behavioral selections remain unknown. Studies have
shown that the basolateral amygdala (BLA) projections to the nucleus accumbens (BLA-NAc) preferentially
encode positive valence, including sucrose and cocaine predictive cues and drive approach behaviors, while
projections to the central nucleus of the amygdala (BLA-CeM) encode negative valence and drive avoidance.
Findings from my K99 phase further demonstrated that neurotensin (NT), a 13 amino acid peptide, released
from the paraventricular nucleus of thalamus (PVT) NT neurons in the BLA can bidirectionally modulate reward
and punishment learning in a concentration-dependent manner (Li et al., Nature, 2023). These findings
suggest that PVT: NT-BLA projection is critical for valence evaluation and can potentially modulate compulsive
reward-seeking in face of punishment. Together, this proposal will investigate how PVT NTergic inputs mediate
the encoding of compulsive reward-seeking and are dysregulated by chronic cocaine self-administration.

Public health relevance
PROJECT NARRATIVE This project aims to explore how neuromodulation, specifically neurotensin, plays a critical role in valence assignment in the basolateral amygdala, a site identified as a divergence point in circuits mediating positive and negative valence. This project will test the hypotheses that neurotensin directs valence-specific information to the appropriate downstream BLA projections during valence processing and modulates compulsive cocaine- seeking behavior. The proposed research project will broaden our understanding of the fundamental neuromodulatory mechanisms underlying valence processing and motivated behavior and identify neurotensin as a novel target for treating valence-disorders including substance use disorders.